Biochemistry in situ to determine inheritance of RNA-protein complexes

Project Summary
The overall objective of this proposal is to elucidate how RNA-protein complexes assemble to
transmit information across animal generations. Which RNA binding proteins are inherited? Which
cells inherit these proteins? What protein attributes are required for inheritance? Answering these
questions require the development of new in situ biochemical methods to label and track specific
RNA binding proteins. The lab uses the C. elegans model organism, modern gene editing
methods, and newer imaging tags to label and track germ cell RNA-protein condensate
components in animals. The strategy requires a significant amount of gene editing and molecular
genetic screening to identify animals with the proper genetic modifications. This supplement
requests partial support to purchase a shared-use, gel and immunoblot imaging system. The
equipment will be used to help identify animals with the correct genotypes, gene modifications,
and protein expression. Institutional support will be provided to enable additional use by the
science community. The imager will enable efficient generation of animals necessary to study
RNA binding protein inheritance in cells and progeny.

Public health relevance
Project Narrative The parent proposal utilizes a protein labeling method to track proteins made in animals and passed to their progeny. This grant supplement, paired with institutional support, will provide funds to purchase a gel and immunoblot imaging system to enable efficient screening of animals for proper genotypes. This equipment will enable the faster acquisition of genetically modified animals to study the proteins and protein attributes required for maternal inheritance.